IMMPORT system maintenance and user support

The ImmPort)system was developed under the Bioinformatics Integration Support Contract (BISC) Phase II by the Northrop Grumman Information Technology Health Solutions team for the National Institutes of Health (NIH), National Institute of Allergy and Infectious Diseases (NIAID), Division of Allergy, Immunology, and Transplantation (DAIT). The goals of the ImmPort system are to: Accelerate a more collaborative and coordinated research environment Create an integrated database that broadens the usefulness of scientific data and advances hypothesis-driven and hypothesis-generating research Advance the pace and quality of scientific discovery while extending the value of scientific data in all areas of immunological research Integrate relevant data sets from participating laboratories, public and government databases, and private data sources Promote rapid availability of important findings, making new discoveries available to the research community for further analysis and interpretation Provide analysis tools to advance immunological research